Designing Differentiated PrEP Service Delivery Models for Implementation in New York City Emergency Departments through a Community Collaborative

PROJECT SUMMARY. HIV pre-exposure prophylaxis (PrEP) is a highly effective method to decrease HIV transmission that remains underutilized. This submission is a planning project to engage a Community Collaborative of providers and users of ED services, community-based organization (CBO) staff, and policymakers to develop a set of strategies to incorporate PrEP services in Emergency Departments (EDs) in the four most highly burdened counties in New York State. We will address the “Prevent Pillar” of the Ending the HIV Epidemic by using an intersectional lens to address key social and structural determinants of HIV. Specifically, offering PrEP in the ED will broaden access to this prevention tool to populations experiencing intersecting vulnerabilities affecting access to health care (e.g., racism, homophobia/transphobia, unstable housing), as these individuals frequently present in EDs for non-emergent care. The proposed work is framed by the Consolidated Framework for Implementation Research (CFIR) and addresses early steps in the PrEP cascade (screening/identification, education/offer of PrEP, PrEP uptake, linkage to primary care). The Specific Aims are to form and work together with a Community Collaborative to: 1) Use data from 40 interviews we will conduct with a wide network of stakeholders (ED staff/clinicians and patients, CBO program staff, and ED administrators that have successfully integrated PrEP in other US hospitals) to identify implementation strategies to address challenges to offering PrEP in urban EDs in high HIV prevalence settings serving sizable populations of vulnerable individuals, and 2) Develop a Toolkit of PrEP service delivery implementation strategies for EDs informed by the Collaborative’s deliberations and review of the stakeholder data. Aims are informed by pilot interviews with ED leaders in our target counties, who described EDs as appropriate sites to identify individuals who could benefit from PrEP but do not have access to it. Yet, despite the potential of EDs to integrate PrEP and promote its uptake, multiple institutional, provider and patient-level challenges need to be addressed. The Collaborative will work with the investigators to iteratively identify what is known and not known (in order to guide the stakeholder interviews), draw on data being collected through these interviews, apply their own knowledge, experience, and expertise, and then formulate a set of strategies to address the challenges associated with providing PrEP in the ED and linking users to ongoing primary care. The primary product(s) of the collaborative are a set of ED-based PrEP implementation strategies, tailored to the needs of individuals with intersecting vulnerabilities. As no single approach will work in all EDs, we will “package” each strategy, describing its implementation elements (core components, critical resources, staffing, institutional commitments, protocols/workflows) to create a comprehensive Toolkit from which facilities can select to use in their setting. In a future study, we will evaluate these strategies in a diverse set of NYC EDs that serve economically and socially disadvantaged individuals in high HIV prevalence areas.

Public health relevance
PROJECT RELEVANCE. This project engages a collaborative of community partners to develop a Toolkit of strategies to deliver HIV pre-exposure prophylaxis (PrEP) services in Emergency Departments (ED) in the most highly burdened counties in New York State; the overall goal of the collaborative is to develop a toolkit of strategies to address the social and structural challenges to PrEP access by identifying ED users who could benefit from this medication, prescribe PrEP in the ED, and link these individuals to primary care to maintain PrEP. Offering PrEP in EDs will enable populations experiencing intersectional vulnerabilities who may benefit from PrEP but are missed by other PrEP initiatives to access it, as EDs may be one of the only settings where they routinely access care. Thus, not only does our project develop community-based strategies to reduce HIV transmission to be tested in a future study; it links vulnerable people to primary care.